TDP-43 LLPS and mitochondrial dysfunction in neurodegeneration

PROJECT SUMMARY
Autosomal dominant mutations in TDP-43 (transactive response DNA binding protein of 43 kDa) are associated
with amyotrophic lateral sclerosis (ALS), the most common motor disease characterized by progressive motor
neuron degeneration in the brain stem and spinal cord. And, TDP-43 has been increasingly recognized as the
common hallmark disease protein for a wide range of neurodegenerative diseases including ALS, frontotemporal
dementia (FTD), limbic-predominant age-related TDP-43 encephalopathy (LATE), cerebral age-related TDP-43
with sclerosis (CARTS), Alzheimer's Disease (AD), and other AD related dementias (ADRD). Mitochondria are
closely linked to neurodegeneration, and have been implicated as a critical target of TDP-43. Previous studies
have established that TDP-43 can undergo liquid-liquid phase separation (LLPS), a dynamic process by which
cells sequester biomolecules into membraneless condensates. Despite a growing body of evidence indicating
the significant involvement of mitochondria and LLPS in TDP-43 related neurodegeneration, whether and how
mitochondria and LLPS-mediated TDP-43 condensates interact and relate to one another remain largely
unknown, presenting a compelling area of research about the intricate mechanisms underlying
neurodegenerative diseases. Based on recently generated cell and mouse models, our pilot studies have found
significantly increased oxygen consumption in response to LLPS loss, revealing an unexpected role of TDP-43
LLPS in the regulation of mitochondrial bioenergetics. Cytosolic condensations of TDP-43 are dynamically
associated with mitochondria, and notably, the inhibition of LLPS not only significantly suppresses TDP-43
mitochondrial localization, but also strikingly alleviates TDP-43-induced mitochondrial dysfunction and neuronal
loss, underscoring the critical role of LLPS and mitochondria interaction. Using multiple cell and animal models
with altered TDP-43 LLPS, this project will systematically investigate whether and how LLPS regulates TDP-43
mitochondrial localization, and contributes to TDP-43 induced mitochondrial and neuronal dysfunction in vitro
and in vivo. The presence of TDP-43 proteinopathy is a prominent pathological hallmark found in a spectrum of
major neurodegenerative diseases, which includes ALS and AD/ADRD. The proposed investigations into TDP-
43 LLPS, its interactions with mitochondria, and its role in driving neuronal loss and disease progression in
mouse models are important for our understanding of neurodegenerative diseases at a broad and fundamental
level.

Public health relevance
Narrative The cytoplasmic mislocalization of TDP-43 and mitochondrial dysfunction are two prominent and common pathological features of degenerating neurons in patients with various major neurodegenerative diseases including amyotrophic lateral sclerosis (ALS), frontotemporal dementia (FTD), limbic-predominant age-related TDP-43 encephalopathy (LATE), cerebral age-related TDP-43 with sclerosis (CARTS), Alzheimer's disease (AD) and other AD related dementia (ADRD). Liquid– liquid phase separation has been increasingly implicated in TDP-43-associated neurodegeneration. Based our recent published and pilot studies, we will investigate whether and how liquid–liquid phase separation regulates TDP-43-medaited mitochondrial and neuronal dysfunction, and contributes to disease progression.